Research Development Core

The Research Development Core (RD Core) assists investigators at any institution in the country with their
research and careers in geroscience. Projects are proposed by external investigators and carried out by our
research Cores. Via these awards we support collaborations between these investigators and the San Antonio
Shock Center Core leaders/Core staff. These collaborations provide multiple opportunities for mentoring
and career development for the awardees and generate pilot data for their research in geroscience. This is
accomplished through these Specific Aims:
1. To support pilot projects proposed by external investigators and carried out by our research Cores,
together with associated training and career development.
2. To offer internships in the Cores to student and postdoctoral trainees via the San Antonio Shock Center
Internship Program.
3. To offer pilot project grants to local investigators in San Antonio to assist these investigators with their
projects in geroscience.
Aim 1 projects are collaborations between the investigator and leaders of the relevant research Cores and
involve training in specific techniques by the Core leaders and staff who provide mentoring in scientific thinking
generally, especially in research in the biology of aging. When the project is sufficiently developed, the RD Core
leaders and the research Core leaders work to assist the external investigator with developing grant proposals
for extramural funding, particularly NIA funding. Additionally, mini-sabbaticals enable investigators to come to
San Antonio and will be offered to investigators with the approval of the executive committee. Aim 2 internships
will be available on a competitive basis and available to trainees working in any area related to the biology of
aging. We will advertise the program via the NSC3 to other institutions with programs in aging research and
trainees will be able to apply to come to San Antonio to work with Core leaders, learn new techniques, and assist
the progress of their projects at their home institution. The program in Aim 3 will continue to support the large
numbers of faculty members at our institution with research in geroscience, particularly those newly recruited to
the university or new to aging research. To ensure that the investigator receives appropriate mentoring at all
stages of the project, a mentoring team is formed among the RD Core leaders and a panel of local experts to
discuss the progress of the work. These teams also help the investigator submit proposals for extramural funding
from the NIA and other sources. Overall, the aims for this Core will promote significant and innovative
research in geroscience and will catalyze the career success of scientists both within the institution and the
nation. While building on our past successes, we also expand innovative aspects that serve to enhance the
effectiveness of this essential Core.